World Congress of Psychiatric Genetics

Project Summary/Abstract
This is a renewal request for Conference Support for the World Congress of
Psychiatric Genetics (WCPG). This Congress has been organized annually by the
International Society of Psychiatric Genetics (ISPG) since 1993, and annual meetings
are being planned for the next five years and beyond. It is the most prestigious
international forum for research in genetic factors affecting psychiatric conditions. During
the last grant period (2013-2017) this program supported 34 Travel Awardees. We have
also contributed to the development of an Early Career Investigator Program (ECIP) at
the WCPG, which includes awardees supported by the ISPG itself. We have supported
three symposia at the conference addressing the genetics of alcohol use and alcohol
use disorders. Through a rapporteur program supported by the ECIP, summaries of the
Congress sessions have been prepared by young investigators and published each year
in the journal Psychiatric Genetics. An average of 700 scientists from around the world
attend the meeting each year.

Public health relevance
PROJECT NARRATIVE: This is a request for support for the annual World Congress of Psychiatric Genetics, sponsored by the International Society of Psychiatric Genetics (ISPG). The requested support will permit the selection of 5-7 Young Investigators per year for the next five years to receive travel support for the Congress.